TREATMENT OF PATIENTS WITH CHRONIC HEPATITIS C TO EVALUATE R-842

This study is designed to study the safety and efficacy of R842 in the treatment of patients with chronic hepatitis C virus infection.